Estimating the impact of the school-to-prison pipeline on adolescent health: spatial differences in policing, school discipline, substance use, and mental illness

Over 10 million students in the US attend schools with police but no counselor, nurse, psychologist, or social worker. Yet, more than a third of the low proportion of adolescents who receive the substance use treatment they need (6%) access it only at school. Schools are thus crucial public health intervention targets for substance use and behavioral health treatment and prevention. But instead, many adolescents experience school as a school-to-prison pipeline; a set of policies and practices that criminalize adolescents and ensnare them in the legal system rather than provide support for underlying educational and developmental needs. School-based arrests increased 300-500% and exclusionary school discipline (suspensions and expulsions) doubled over the past 40 years. Some subgroups of students are more than three times as likely to be suspended or expelled as other students, and students removed from school are more than twice as likely to be arrested in the same month than those not removed. Our preliminary evidence suggests that the school-to-prison pipeline is a previously unidentified population driver of adolescent substance use and mental illness. Moreover, the pipeline coincides with rises in aggressive community policing in schools’ surrounding communities. However, there is no research on the public health implications of these intersecting trends. In the proposed R01, we will collaborate with the New York City Office of School Health (OSH) to quantify relationships between aggressive community policing, school discipline, and student substance use/mental illness in NYC. We will create a unique geocoded 2000-2022 dataset linking all police stops/arrests; school- and student-level exclusionary discipline; restricted school-level Youth Risk Behavior Survey (YRBS) data (e.g., tobacco, alcohol, cannabis, other drug use); and OSH’s database of student health services records (e.g., nurse, counselor visits, referrals to behavioral health/substance use treatment). We will (Aim 1) characterize direct and mediated relationships between community policing and school discipline on school-level and (Aim 2) student-level substance use and behavioral health outcomes; and test (Aim 3) whether the intensity of policing around schools modifies the relationship between school discipline and student substance use/mental health. This high-impact project responds to NIDA’s interest in improving SUD treatment for at-risk populations in schools and the juvenile legal system, as well as leveraging data science to improve SUD prevention. Our interdisciplinary team, led by an early-stage investigator PI, has expertise in substance use, psychiatric, and social epidemiology; school health; the sociology of group differences in population health, education, and policing; spatial epidemiology/health geography; and data science. Findings will be utilized by policymakers and project stakeholders (including city, state, and federal policymakers) working to end the school-to-prison pipeline and prevent adolescent substance use/mental illness.

Public health relevance
Aggressive community policing, school discipline, and the school-to-prison pipeline criminalize adolescents and ensnare them in the legal system rather than provide support for underlying educational and developmental needs; these phenomena are a hypothesized population driver of adolescent substance use and behavioral health problems. We will collaborate with the New York City Office of School Health to create unprecedented, geocoded, longitudinal data linkages between police stops/arrests; school- and student-level exclusionary discipline records; and restricted school- and student-level substance use/behavioral health records. We will estimate direct and mediated relationships between community policing and school discipline on school- and student-level substance use and mental health outcomes; and test whether the spatial concentration of policing around schools modifies these relationships.